Brain and Human Body Modeling Conference (BHBM) – from Fast and Accurate Computational Modeling to Clinical Practice

Modified Project Summary/Abstract Section

Brain stimulation therapies are important and effective treatments for people with depression and other mental disorders. The National Institute of Mental Health (NIMH) is supporting studies exploring how to make brain stimulation therapies more personalized and effective while reducing side effects. For all brain stimulation modalities, computational numerical modeling of the electric, magnetic and acoustic fields within a patient-specific head model is the leading and most promising way to develop improved spatial targeting methods and quantitatively determine the required stimulation dose. Similarly, neurophysiological signal analyses require extensive numerical computational modeling to identify active cortical domains from limited electrode voltage and magnetometer measurements. The present proposal will facilitate development of fast and accurate brain and human body modeling methods and techniques via a dedicated and growing computational conference on Brain and Human Body Modeling. Aligned with NIMH’s mission, the specific aims of this proposal will include the following:
(i) Exchanging ideas, methods, and approaches on computational modeling electric and magnetic fields within the brain targeting neurostimulation modalities (TMS, TES, DBS, tFUS) and associated neurophysiological recordings (EEG, iEEG, MEG);
(ii) Integration of modeling techniques into clinical practice;
(iii) Hands-on training to keep pace with the rapidly evolving technologies by introducing four dedicated workshops in total as an integral part of the conference agenda;
(iv) Participation by leading industry subject matter experts in the form of dedicated presentations, demonstrations, and booths/banners which will enable networking opportunities, multi-disciplinary collaboration, and potential employment in high-tech markets.
The modeling techniques to be presented and discussed are aimed at providing better focality, targeting accuracy, and improve the overall efficiency of brain stimulation methods. They will also support promising combinations and derivatives of neuromodulation and neurophysiological recordings such as TMS-EEG and TES-EEG. No established computational methods for modeling these combined modalities currently exist.
The conference will include related topics that share very similar, sometimes identical, computational methods and tools. We aim to synergistically share these computational tools for maximal benefit and to facilitate interactions across disciplines.

Public health relevance
NARRATIVE To enable development of fast and accurate brain and human body modeling methods and their transition to clinical practice via a dedicated computational conference on Brain and Human Body Modeling aligned with NIMH mission.